Mechanisms of Microbiota-Immune Interactions-Towards the Next Decade

ABSTRACT
Support is requested for a Keystone Symposia conference entitled Mechanisms of Microbiota-Immune
Interactions-Towards the Next Decade, organized by Drs. Jorge Henao-Mejia, Eran Elinav and Lora Hooper.
The conference will be held in Snowbird, Utah from October 8-11, 2023.
At different stages of life, interactions between the host microbiota and the immune system play critical roles in
protective immune responses against pathogens and determine the efficacy of vaccines and immunotherapies.
Moreover, in most tissues of mammalian organisms, alterations in the composition of the host microbiota
significantly contribute to chronic inflammatory processes. However, the mechanisms by which the microbiota
regulates the immune system in multiple tissues and at different life stages, in the context of health and disease,
remains largely undetermined. This conference will bring together leading experts in the field who are currently
developing novel approaches in genomics, metagenomics, metabolomics and imaging technologies, to establish
the mechanisms by which specific components of the microbiota regulate immune responses in different tissue
contexts. In addition, this conference is being held jointly with the Keystone Symposia conference on Circulating
Metabolic Intermediates as Fuels and Signals. It is anticipated that this pairing will lead to new scientific
collaborations, the development of new technological approaches directed at understanding the underlying
mechanisms of microbiota-immune interactions, and the nucleation of academic-industrial interactions that will
translate basic mechanistic insights in the field into new therapeutic modalities.

Public health relevance
PROJECT NARRATIVE Discoveries over the past two decades have revealed the importance of microbiota-host interactions as key regulators of host physiology and immune responses. Alongside the explosion of research that has defined this field, it is evident that a deeper understanding of how the microbiota regulates host physiology and immune responses in health and disease will be essential to advance future research. This Keystone Symposia conference will bring together academic and industrial researchers from across the globe to discuss the latest science and concepts in the field and provide an opportunity for attendees to build new collaborations to support the advancement of knowledge in the area and facilitate its translation into clinical applications.